Multi-sector, multi-level interventions for improving cancer prevention and control addressing persistent poverty

OVERALL: PROJECT SUMMARY
The overall, long-term goal of “HOPE & CAIRHE 2gether (HC2)” is to increase the reach of evidence-based
cancer prevention and control interventions (EBIs) in areas of persistent poverty (PP). HC2 brings together the
expertise, infrastructure, partnerships, and resources of the Center for Health Outcomes and Population Equity
(HOPE), Huntsman Cancer Institute, and University of Utah, with the Center for American Indian and Rural
Health Equity (CAIRHE) and Montana State University. HC2’s community level, translational research
programs align with communities’ cultural beliefs, resources, and priorities; reach across the lifespan; and,
strategically partner with key “anchor organizations,” public health agencies, healthcare systems, American
Indian communities, and community organizations across five states. The HC2 Network brings together the
robust community partnerships across institutions to create a unique resource for advancing cancer prevention
in PP areas in the Mountain West, and HC2 is guided by a Community and Scientific Advisory Board. Projects
1 and 2 address the major drivers of the disproportionate burden of cancer among PP areas and populations.
Project 1 partners with Community Health Centers (CHCs) to address tobacco cessation and mitigate the
negative impacts of the social determinants of health (SDOH) among CHC patients in Utah who use tobacco
and live in PP census tracts (majority Latino). Project 2 partners with Cooperative Extension Systems (CES) to
address obesity prevention and SDOH among American Indian communities located in PP census tracts in
Montana, Oregon, South Dakota, and Wisconsin (all census tracts are rural/frontier). Both Projects include
Project Steering Committees and Project 2 includes Local Community Advisory Boards in each community.
An overarching theme creating synergy across HC2 activities and research is increasing “Reach through
Equitable Implementation.” As such, HC2 implementation strategies are specifically tailored to local and
community contexts. HC2’s structure and function creates substantial synergy to advance cancer prevention
research in areas and populations experiencing persistent poverty via: Complementary areas of expertise,
experience, community engagement, and leadership across institutions; Innovative, comprehensive, multi-
level, conceptual framework targeting Reach through Equitable Implementation, with shared research foci
that drive the research programs; Multi-faceted, cross-institutional training program that leverages the
complementary strengths and access to trainee populations across Utah and Montana; and, Combining deep
and extensive community engagement and robust partnerships across institutions to create the HC2 Network,
which will help bridge the gap between scientific discovery and the implementation of EBIs in areas of PP. In
sum, HC2 will build on existing expertise, research infrastructures, and longstanding partnerships to serve as a
regional and national leader in community-engaged cancer prevention and control research in areas of PP.

Public health relevance
OVERALL: PROJECT NARRATIVE HOPE & CAIRHE 2gether (HC2) brings together the expertise, infrastructure, partnerships, and resources of the Center for Health Outcomes and Population Equity (HOPE), Huntsman Cancer Institute, and University of Utah, with the Center for American Indian and Rural Health Equity (CAIRHE) and Montana State University. The overall, long-term goal of HC2 is to increase the reach of evidence-based cancer prevention and control interventions in areas of persistent poverty. The two research projects will work in persistent poverty census tracts and in partnership with Community Health Centers in Utah, and with Cooperative Extension Systems and American Indian communities in Montana, Oregon, South Dakota, and Wisconsin, to mitigate adverse impacts of the social determinants of health, increase tobacco cessation, and prevent obesity.